Roles of human surfactant collectin variants in the susceptibility of COVID-19

More than 4.8 million people have died due to coronavirus disease 2019 (COVID-19) in less than two years.
COVID-19 is an infectious disease caused by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2).
Morbidity and mortality following SARS-CoV-2 infection are predominantly due to a robust influx of inflammatory
cells and cytokines into the lungs resulting in acute lung injury (ALI) and acute respiratory distress syndrome
(ARDS). Individuals exhibited different degree of disease severity after SARS-CoV-2 infection. Human
Surfactant proteins A and D (hSP-A and hSP-D), two members of C-type lectin (surfactant collectin), are
pattern recognition proteins, and they play a critical role as a first-line host defense and innate immunity in the
mucosal surfaces of the lung and other organs. Our preliminary data and recent in vitro studies demonstrated
that hSP-A and hSP-D can bind to SARS-CoV-2 Spike protein and inhibit viral entry and replication in lung
epithelial cells. Interestingly, the genes of hSP-A and hSP-D are highly polymorphic, and several genetic variants
(alleles) for each of them have been identified in the general population. However, the mechanistic roles of hSP-
A and hSP-D genetic variants in the pathogenesis of COVID-19 are unknow. The long-term goal is to determine
the roles of hSP-A and hSP-D genetic variants in susceptibility and severity to SARS-CoV-2-induced ALI/ARDS
and to develop novel variant-specific therapeutic drug for the treatment of COVID-19. This proposal aims to
determine molecular interaction of surfactant collection and Spike protein, and define the mechanistic roles of
hSP-A and hSP-D genetic variants causing individual susceptibilities to COVID-19. Our central hypothesis is that
hSP-A and hSP-D genetic variants differentially influence susceptibility and severity to SARS-CoV-2-induced
ALI/ARDS by inhibiting SARS-CoV-2 infectivity and modulating mucosal innate immunity and pathophysiology.
Recently, we have generated a new double-humanized transgenic (double-hTG) mouse model, which
express human angiotensin-converting enzyme-2 (SARS-CoV-2 cognate receptor) and hSP-A or hSP-D genetic
variant. This double-hTG model provides us with a powerful tool to study the innate immune response and
mechanistic roles of hSP-A and hSP-D variants following SARS-CoV-2 infection. We propose two specific aims
to test our hypothesis: Aim 1: Study the interactions of hSP-A or hSP-D genetic variants with SARS-CoV-2 spike
protein and the inhibitory effect on viral entry and replication in lung epithelial cells. Aim 2: Define the differential
roles of hSP-A genetic variants in inhibiting viral infectivity and modulating SARS-CoV-2-induced ALI through
regulating TLRs/NF-kB/IFN signaling in a double-hTG mouse model. The proposal is strongly supported by our
preliminary data and available novel double-hTG model suitable for COVID-19 study. We expect that the
successful completion of the proposed studies will establish a novel COVID-19 murine model, and have a better
understanding of the innate immune roles of hSP-A and hSP-D in COVID-19 pathogenesis that is crucial to
develop novel immunomodulatory therapies and personalized medicine.

Public health relevance
The proposed research is relevant to public health because, with a detailed understanding of how human surfactant proteins A and D impact the innate immunity of human beings in COVID-19 disease, it will be possible to design new therapeutic strategies for COVID-19 treatment. We will define the roles of human surfactant protein A and D genetic variant in the susceptibility of COVID-19.